Immunologic Responses to Cow's Milk Proteins in IgE-mediated Cow's Milk Allergy

Cow's milk is the most common cause of food allergy in children, with approximately 1.8% of American infants developing IgE-mediated allergic reactions to cow's milk [~74,000 cases/year]. While -80%